Transposable Elements at the Crossroads of Evolution, Health and Disease

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Transposable Elements at the Crossroads
of Evolution, Health and Disease, organized by Drs. Kathleen Burns, Harmit Malik and Irina Arkhipova. The
conference will be held in Whistler, British Columbia, Canada from September 3-6, 2023.
Transposable elements are omnipresent in every domain of life and play an eminent role in shaping biological
properties of living organisms. The field of transposon research has significantly expanded with the realization
that mobile DNA constitutes a major component of most genomes and that transposable element sequences,
while generally mutagenic, can be co-opted to benefit the host species. Moreover, rapid development of tools
to study transposon activities enables the efforts to differentiate their causal and epiphenomenal effects. There
is a pressing need to understand the many ways in which mobile DNA affects genome evolution and shapes its
function under normal and pathological states. The aims of this conference are to: 1) Apply recent advances in
genomics, proteomics and bioinformatics towards an overview of transposon integration into genomic
compartments, epigenetic processes and regulatory networks over evolutionary time scales; 2) Expand
structural and mechanistic insights into the nature of transposition processes affecting genome dynamics and
integrity; 3) Close the gaps in understanding transposon mobilization and its control at the molecular, cellular,
organismal, and population levels, highlighting the impact on carcinogenesis, neurodegeneration and aging; 4)
Showcase the applications of fundamental knowledge on mobile element-host interactions to the burgeoning
fields of genome engineering, biomedicine, plant and environmental sciences. Accelerating advances in the
field will attract new investigators who will benefit greatly from this conference, while giving the long-standing
experts reasons to reconvene, share methodologies, and promote new collaborations between leading
international groups on the broadest possible scale, exploring all kingdoms of life.

Public health relevance
PROJECT NARRATIVE Transposable element biology is a fundamental field, and these elements are found in every domain of life because they play a fundamental role in shaping biological properties of living organisms. As such, there is a pressing need to understand the many ways in which mobile DNA affects genome evolution and genome function under normal and pathological states. The conference is expected to stimulate collaborations and interactions between groups and provide a venue for trainees and investigators new to the field to become familiar with key questions driving the field.